GROWTH IN CEREBRAL PALSY

Children with cerebral palsy (CP) sometimes do not grow normally, and there can be multiple causes for this. Some of the causes can be treated if the problem is recognized; other causes cannot be treated. The purpose of this study is to assess growth in large numbers of children with cerebral palsy. This will give a much clearer understanding of growth in CP, which in turn will help us to more easily recognize if a child with CP has a growth problem.